Intermountain West Clinical Site for the Undiagnosed Disease Network (UDN) Phase 2 Supplement

PROJECT SUMMARY/ABSTRACT
Year 5 of the Intermountain West Clinical Site (University of Utah) for the Undiagnosed Disease Network will
be focused on completing the evaluation of participants enrolled by June 30, 2022. Because of the pause in
accepting participants by other sites, the Intermountain West Clinical Site has been receiving in year 4 a
several-fold increase of applications from a wider geographic catchment area than was originally assigned to
the site. This increased amount of effort in year 4 will translate in increased number of participants accepted in
year 4 and having to be evaluated in year 5. The evaluation will follow the UDN protocols with the goal in year
5 of completing all evaluations accepted in year 4. The Intermountain West Clinical Site will bring the team,
experience, resources, and institutional support to advance the shared goal of UDN – improve the diagnosis
and management of difficult-to-diagnose and new diseases—efficiently, equitably, and sustainably.

Public health relevance
PROJECT NARRATIVE The Intermountain West Clinical Site of the Undiagnosed Disease Network (UDN) will help adults and children with undiagnosed diseases spread across over 10% of the Continental US get access to unprecedented diagnostic and care resources. Because of the pause in application review in some UDN clinical sites, the Intermountain West Clinical Site is evaluating patients from a larger geographic area than previously assigned. The focus of this project period (year 5) is to complete the evaluation of participants accepted through the end of year 4 (June 30,2022). The overall goal is to help families get better care through a precise diagnosis, and in doing so discover new genetic causes, disease pathways, and treatments that will help many more families in future.